Examining Suicide Risk from a Biopsychosocial Framework: A Large-Scale Cross-Sectional Study

PROJECT SUMMARY/ABSTRACT
Suicide remains a significant public health crisis nationally and globally. Suicide-related thoughts and behaviors
are transdiagnostic phenomena associated with heterogeneous biopsychosocial risk indicators. Findings
suggest that suicide risk is associated with distinct resting-state functional connectivity, structural brain
differences, and polygenetic risk score (PRS) profiles. There are notable gaps in our understanding of
biopsychosocial vulnerabilities for suicide. The first research gap involves a lack of in-depth understanding of
candidate markers for differentiating between individuals who only think about self-directed violence versus those
who ultimately attempt suicide. The second research gap involves a lack of an in-depth understanding of how
biological risk indicators in combination with psychosocial risk indicators contribute to suicide risk. Understanding
the biopsychosocial risk profile for individuals most at risk for eventual death by suicide remains critical for
enhancing suicide risk detection strategies and developing targeted interventions. To address these gaps, the
overall objective of the proposed project is to investigate the combined associations of brain structure and
connectivity, genetic, and behavioral risk indicators for suicide. Biopsychosocial data from an estimated
4566 participants drawn from the UK Biobank will be analyzed to differentiate those at risk for suicidal behavior
from self-directed violence thoughts alone. This proposal sets the stage for Mr. Thompson’s goal to develop a
program of research investigating biopsychosocial markers of suicide risk. Aim 1 of the proposed project is to
compare brain structure and connectivity, genetic, and psychosocial risk indicators between two groups: adults
with lifetime suicide attempt(s) and adults with lifetime self-directed violence thoughts alone. Aim 2 is to
determine the relative importance of biological and psychosocial candidate markers by comparing classification
algorithms utilizing biological (i.e., brain structure and connectivity, genetic variance), above and beyond
psychosocial risk indicators alone, in differentiating between these two groups. Findings will advance our
understanding of the biopsychosocial risk indicators associated with suicide to highlight mechanisms, improve
risk detection, and ultimately inform targeted intervention strategies. Overall, the goals of the proposed project
will be accomplished within the context of a research training program aimed at developing expertise in (1)
biopsychosocial underpinnings of suicidality, (2) advanced statistics and machine learning, (3) multimodal
neuroimaging, (4) generation of PRS, and (5) scholarly dissemination skills. The training plan includes
attendance at selected workshops, scientific writing and academic conference presentations, and individual
supervision and mentorship by a team of sponsors and collaborators with complementary areas of expertise.

Public health relevance
PROJECT NARRATIVE The overall objective of the proposed project is to investigate the combined associations of brain structure and connectivity, genetic, and behavioral risk indicators for suicide. Biopsychosocial data from an estimated 4566 participants drawn from the UK Biobank will be analyzed to differentiate individuals with lifetime suicide attempt(s) from those with lifetime self-directed violence thoughts alone. This systematic examination of biological and psychosocial correlates of suicide will highlight mechanisms, advance suicide risk detection, and ultimately inform targeted interventions.